SCAMP3 as a regulator of EGFR/STAT3 axis in triple-negative breast cancer

Project Summary
This proposal will investigate the molecular drivers that contribute to the progression of one of the most
aggressive and metastatic types of breast cancer. Triple Negative Breast Cancer (TNBC) is characterized by the
lack of hormone receptors (estrogen and progesterone) and HER2 expression and accounts for approximately
20% of all breast cancers. Due to its heterogeneity and dearth of defined specific molecular targets, TNBC
treatment remains challenging. Accordingly, this study seeks to elucidate the molecular role of secretory carrier-
associated membrane protein 3 (SCAMP3) on TNBC pathogenesis, with the goal of developing new therapies
that will improve the survival rate of patients. Recently, SCAMP3 has been found overexpressed and associated
with poor prognosis in hepatocellular carcinoma, melanoma, glioma, and breast cancer, suggesting that
SCAMP3 has a key role in oncogenesis. However, the molecular mechanisms of how SCAMP3 promotes TNBC
progression are poorly understood. SCAMP3 is a regulator of epidermal growth factor receptor (EGFR) trafficking
within endosomal membranes promoting receptor recycling. EGFR mediated endocytosis is a mechanism of
transport of cancer-associated signaling proteins, such as signal transducer and activator of transcription 3
(STAT3). EGFR and STAT3 have been associated with TNBC proliferation, invasion, metastasis, and cancer
stem cell (CSC) maintenance. Our objectives are to determine the mechanisms by which SCAMP3 promotes
TNBC progression and determine the interplay between SCAMP3/EGFR and STAT3 signaling pathways. We
hypothesize that: 1) SCAMP3/EGFR mediated endocytosis regulates the activation of STAT3. 2) SCAMP3
signaling pathway promotes and maintains TNBC stemness via the modulation of EGFR/STAT3, and 3)
SCAMP3 contributes to TNBC tumor formation and metastasis. To test these hypotheses, we propose the
following aims: 1) To elucidate the mechanism of action of SCAMP3 on STAT3 activation; 2) Define the role of
SCAMP3 in TNBC and CSCs regulation via STAT3 modulation: 2a) To elucidate the molecular mechanisms of
SCAMP3 in CSCs maintenance in vitro; 2b) To investigate the effect of SCAMP3 in tumorigenesis and
metastasis. We propose experiments that will monitor EGFR and STAT3 internalization, STAT3 DNA-binding
activity, and transcriptional activity. We will identify the relevant driver genes that maintain cancer stemness in
SCAMP3 overexpressing cells using RNAseq, which will be confirmed in patient samples. The studies have the
potential to be rapidly translated to the clinic and significantly reduce the incidence and number of deaths related
to TNBC.

Public health relevance
Project Narrative Triple-negative breast cancer (TNBC) is considered to be more aggressive and have a poorer prognosis than other types of breast cancer, mainly because there are fewer targeted medicines that treat this subtype. This research will clearly define the molecular mechanisms behind TNBC progression, in efforts to reduce the incidence and number of deaths related to it. This work will contribute to further development of new therapies that will improve the chemotherapeutic efficacy of TNBC patients.